The Effects of Changes in Local Alcohol Policies and Enforcement on Alcohol Use and Impaired Driving

Project Summary
The goal of this project is to assess how changes in local alcohol policy and enforcement are associated with
excessive alcohol use and alcohol-impaired driving. We will use a longitudinal design with local-level policies
and outcome data tracked over a 15-year period, and enforcement of alcohol policies measured at two time
points. We propose to conduct a 5-year longitudinal study to address the following specific aims: (1) assess
the longitudinal associations of individual local alcohol policies with excessive alcohol use and alcohol-impaired
driving; (2) assess the longitudinal association of combinations of local alcohol policies with excessive alcohol
use and alcohol-impaired driving; and (3) assess the longitudinal association of alcohol enforcement at the
local level with excessive alcohol use and alcohol-impaired driving and assess how enforcement influences
associations between alcohol policies and outcomes (effect modification/interaction). The proposal addresses
recommendations from several national-level institutions, provides a tool for future research studies, and will
inform policymakers' decisions about effective strategies to prevent and reduce health and social harms that
result from excessive drinking and impaired driving.

Public health relevance
Project Narrative We propose to conduct a five-year, longitudinal study to assess how changes in local alcohol policy and enforcement are associated with excessive alcohol use and alcohol-impaired driving. We will use a longitudinal design with local-level policies and outcome data tracked over a 15-year period, and enforcement of alcohol policies measured at two time points. Results from this study may inform decisions among policy makers about effective strategies to prevent and reduce health and social harms that result from excessive drinking and impaired driving.